Core A: Administrative and Data Sharing Core

PROJECT SUMMARY: Admin Core A
The objectives of the Administration Core are multi-fold. First, the Admin Core A will serve as the
central organizing group for the U54 FTD Center without Walls. The Admin Core will oversee and direct
all scientific activities of the FTD CWOW and promote collaboration and communication by setting up
monthly meetings between the UCSF and Washington University teams. Secondly, the Core will
provide administrative, financial and organizational support for the investigators. It will produce reports
on Center activities and keep track of milestones and deliverable. The Admin Core will also serve as an
internal data sharing and management hub for the Center. In this way, it both develop new and
leverage existing partnerships for data organization. Finally, the Admin Core will generate and maintain
public facing web resources and databases, including the Tau Metabolism Pathway Database (TMDB)
and the Tau Polygenic Risk Score (TPRS). The Administrative Core will be headed by Dr. Aimee Kao
with Co-Lead Dr. Jennifer Yokoyama. If the Center is awarded, the Core will recruit a Scientific
Advisory Board (SAB), that will advise on the scientific and management aspects of the group. The
SAB will convene annually to advise the CWOW on scientific direction. The Core will work with the NIH
and SAB to supervise the achievement of milestones and deliverables. Ultimately, this Core will be
directly responsible for the CWOW’s productivity, direction and success.